MURINE MODEL OF CD36 MEDIATED SCAVENGER FUNCTION

DESCRIPTION (Adapted from Investigator's Abstract): Recently, CD36, a protein previously characterized as an adhesion molecule, has been shown to be an active transporter of long chain fatty acids, and to play a role in the recognition and uptake of apoptotic cells and shed photoreceptor outer segments. The central premise of this application is that CD36 plays an essential role as a scavenger receptor on monocytes/macrophages and in the specialized epithelium of the retina, and functions as a long chain fatty acid transporter in muscle and adipocytes. The investigators have used targeted homologous recombination to disrupt the CD36 gene in mice. The loss of CD36 is not lethal, but may predispose the animal to tissue damage at times of stress, injury, and overwhelming infection. To this end, they will confirm that these mice are null with respect to CD36 protein and function, and then use them as a model to confirm the hypothesis that CD36-mediated scavenger function is important in normal homeostasis in the context of recognition and uptake of apoptotic cells, which arise through aging, during wound healing, and in inflammatory situations. They will use these mice as a model to study the consequences of the deletion of a long chain fatty acid transporter in lipid storage and metabolism. Finally, they hypothesize that the loss of CD36 may speed progression of eye disease in a constant illumination model. The Specific Aims are 1) characterization of CD36-null mice, 2) characterization of the role of CD36 as a scavenger receptor, and 3) characterization of the role of CD36 in fatty acid metabolism.